Structural Intervention to Promote HIV Care in Black Sexual Minority Men

PROJECT SUMMARY
The goals of this research project are to use the ADAPT-ITT framework to adapt elements of an existing career
readiness interventions tailored to young SMM and trans women of color at-risk for HIV infection
(Work2Prevent) to the needs of young Black SMM (YBSMM), ages 18-29, living with HIV. Once adapted, a
pilot study of the intervention (Work2Prevent Plus; W2P+) will be conducted with 40 YBSMM to determine
intervention feasibility, acceptability, and efficacy for improving care engagement.
To ensure W2P+ can serve the needs of HIV-positive YBSMM, the research team will engage in a formative
phase of adaptation, wherein quantitative and qualitative data will be collected from employers. A sample of
potential employers (n=50) will complete a survey focused on challenges related to hiring and retaining
individuals with a range of minority identities. A second sample (n = 20) of potential employers will complete an
interview with project staff, where they will respond to vignettes focused on successes and challenges a hiring
manager could encounter when trying to hire and retain employees who are YBSMM living with HIV. These
data will inform the adaptation of W2P+. Next, a series of focus groups will be conducted with members of the
population (n = 40) to identify what they most need in a career readiness intervention. More specifically, this
phase will use the ADAPT-ITT framework to ensure the adapted intervention addresses the range of concerns
associated with employment for YBSMM irrespective of HIV status. Next, the research team will conduct a
theater test with 8 YBSMM aged 18-29 years old and 10 stakeholders serving YBSMM, wherein stakeholders
will observe the administration of content from the existing interventions to identify which content should be
retained, adapted, or replaced. Next, 3 to 5 experts on employment and treatment barriers will be asked for
additional feedback for intervention revision. The feedback will be used for additional revision of W2P+. Finally,
a computerized readability test will ensure that language used in the revised intervention manual and activities
is accessible to a 6th grade reading level. After the intervention manual and delivery procedures with the
ADAPT-ITT model are finalized, 40 YBSMM, ages 18-29, will be enrolled in a single arm pilot trial, with follow-
up assessments at 6 and 12 months. The primary research outcomes for the pilot study are feasibility and
acceptability. Additional outcomes include hours worked per week, job seeking self-efficacy, and proportion of
missed HIV care visits.
Further, we will use implementation science measures to identify the best approach for delivering the
intervention in a CBO setting. Primary implementation outcomes are relative advantage of the intervention and
implementation climate. Secondary outcome is readiness for implementation.

Public health relevance
PROJECT NARRATIVE The proposed study focuses on using the ADAPT-ITT framework to adapt material from existing career readiness interventions (Work2Prevent, tailored to young SMM and trans women of color at-risk for HIV infection, and iFOUR, tailored to older people living with HIV, regardless of race) to the needs of young Black SMM (YBSMM), ages 18-29, living with HIV. Given that economic challenges have been demonstrated to limit YBSMM’s engagement in HIV treatment, this intervention has the potential to support HIV-positive YBSMM in improving their economic conditions and associated HIV treatment outcomes. Further, the study uses implementation science methods to understand the context of implementation to prepare for efficient and cost- effective delivery in community-based organizations.